Deciphering novel UPS regulation of Sgf73/ataxin-7 in controlling SAGA and associated functions in gene expression

ABSTRACT:
Sgf73/ataxin-7 is a key component of an evolutionarily conserved transcriptional co-activator SAGA
(Spt-Ada-Gcn5-Acetyltransferase) with two distinct enzymatic activities for chromatin modifications, and is
up- and downregulated in cancer and other diseases such as eye and neurological disorders. Therefore, it
is crucial to understand the regulatory networks lying upstream of Sgf73 towards understanding the
pathogenesis of these diseases with targeted therapeutic interventions. However, it remains largely
unknown how Sgf73 is regulated. In view of this, we carried out a set of experiments which demonstrated
ubiquitylation and proteasomal degradation of Sgf73, thus revealing a novel UPS (Ubiquitin-proteasome
system) regulation of Sgf73. However, the E3 ubiquitin ligase involved in such regulation of Sgf73 is yet
unknown. Further, the physiological relevance of such regulation of Sgf73 on SAGA’s integrity and functions
in controlling gene expression remains largely elusive. Moreover, other factors such as ubiquitin protease
and conjugase involved in Sgf73 ubiquitylation and proteasomal degradation are not yet known. Answers to
these important questions would fundamentally establish novel UPS regulation of Sgf73 in orchestrating
gene expression, thus greatly advancing the field of gene regulation. In addition, these results would have
significant impact on understanding the pathogenesis of cancer and other diseases such as eye and
neurological disorders and future therapeutic development, since Sgf73 is associated with these diseases.
Therefore, we propose to address above questions in this application. Specifically, we aim to (i) identify E3
ubiquitin ligase involved in Sgf73 ubiquitylation and proteasomal degradation, (ii) determine ubiquitylation
site on Sgf73, (iii) determine the physiological relevance/roles of Sgf73 ubiquitylation and proteasomal
degradation in regulation of SAGA’s integrity and functions in gene expression in controlling cellular health,
and (iv) identify ubiquitin conjugase, ubiquitin protease and other factors involved in regulation of Sgf73
ubiquitylation and proteasomal degradation with associated functions. Collective results would identify new
factors involved in regulation of Sgf73 with roles in controlling SAGA and gene expression in maintaining
cellular functions, thus fundamentally advancing our understanding of gene regulation by UPS with
implications in human health.

Public health relevance
Proposal narrative: Altered cellular levels of Sgf73/ataxin-7 is associated with cancer, neurological and eye diseases. This proposal aims to identify the factors involved in regulation of the cellular levels of Sgf73/ataxin-7 with physiological relevance in cellular functions and pathologies. The identified factors can emerge as important biomarkers for cancer, neurological and eye disorders with targeted therapeutic potentials.